Senolytics to Improve Cognition and Mobility in Older Adults at Risk of Alzheimer’s Disease

Abstract/Project Summary
Abnormalities in cognition and mobility are common accompaniments of aging that often precede the
development of Alzheimer’s disease. Among their many etiologies, these abnormalities are associated with
alterations in the regulation of cerebral blood flow to frontal regions of the brain that subserve executive
functions and gait speed. We have previously shown that treatment with cocoa flavanols can improve blood
flow in response to a cognitive task (neurovascular coupling [NVC]), as well as executive function in older
people with impaired NVC. These compounds can also reduce the number of senescent cells and their toxic
secretory products (SASP) in a variety of tissues. In mice, “senolytic” compounds such as flavanols and
tyrosine kinase inhibitors, have been shown to reduce neurofibrillary tangle density, neuron loss, and
ventricular enlargement, and in humans with idiopathic pulmonary fibrosis, improve gait speed and other
functional abilities. Based on these findings, we hypothesize that the flavanol, Quercetin, and tyrosine kinase
inhibitor, Dasatinib, (Q+D) will improve NVC in response to an executive task, reduce circulating SASP
components, and in so doing, improve cognition and mobility in older adults who are at risk of Alzheimer’s
disease. Our specific aims are: 1) To conduct a 12-week single arm, open label, pre-post pilot study to
determine the feasibility and recruitment challenges of studying intermittent doses of Quercetin and Dasatinib
(Q+D) in 12 older adults aged 70 to 90 years with slow gait speed (<1.0 m/sec) and Mild Cognitive Impairment;
2) To obtain preliminary data on the effect of this Q+D regimen on: a) resting cerebral blood flow (CBF) and
neurovascular coupling (NVC) during an executive task, b) gait speed and executive function, and c) other
secondary measures of physical and cognitive performance; and 3) To develop preliminary evidence
concerning whether Q+D is associated with a) a reduction in biomarkers of senescence in serum and urine
and senescent cells in blood, and b) whether reductions in these biomarkers are associated with improvements
in NVC, gait speed, and executive function. This research will leverage the expertise and resources of the
Boston Pepper Center and Mayo Clinic-based Translational Geroscience Network. Its results may identify a
novel approach for improving cerebral blood flow regulation, mobility, and cognition in older adults, and
preventing their progression to Alzheimer’s disease. The study may also help establish proof-of-concept that
the cognitive and functional disabilities of older age may arise, in part, from the secretory products of
senescent cells and be alleviated by senolytic agents.

Public health relevance
Narrative: The long-term goal of this study is to prevent common age-related impairments in cognition and mobility that lead to the development of Alzheimer’s disease by interrupting one of the fundamental mechanisms of aging, namely the accumulation of senescent cells and their damaging products. We will determine the feasibility of administering Quercetin and Dasatinib to eliminate these cells from the body, and test whether their elimination can improve brain blood flow, cognition, and mobility in older adults at risk of developing Alzheimer’s disease.